Innate Immunomodulation of Retinal Vascular Development

Project Summary
Retinal blood vessel formation is a highly regulated process that requires multi-cellular crosstalk and
interactions. Due to the complexity of retinal vascular development, there are several critical knowledge gaps
that need to be addressed. For example, the key glial cell type that regulate retinal vascular development are
astrocytes, which lay a template for blood vessel formation. Endothelial cells migrate over the spatially
organized astrocytic template to form superficial blood vessels that give rise to three interconnected vascular
layers in the mature retina. Disruption of the astrocytic template during development or loss of astrocyte
association with blood vessels in adulthood can be detrimental to vascular growth, integrity, and function. The
underlying cellular and molecular signaling mechanisms that regulate astrocyte spatial patterning and
subsequent organized blood vessel formation during development remain incompletely understood. Elucidating
the molecular mechanisms that govern blood vessel development and function is necessary to identify more
targeted therapeutic strategies for blinding retinal vascular pathologies, and to identify which critical
developmental processes should not be targeted in some contexts, for example retinopathy of prematurity. Our
major goal is to delineate the signaling mechanisms that regulate astrocyte template spatial arrangement and
vascular network formation.
Our preliminary findings strongly support the rationale for the present study. Our RNA-seq data reveal that
specific chemokine and complement gene expression levels are elevated during retinal vascular development.
Intriguingly, deletion of one of the affected chemokine receptors disrupts astrocyte template formation and
microglial recruitment and distribution. On the other hand, deletion of complement components results in an
aberrantly dense astrocytic template and dysmorphic excessive tip cell formation. Based on these novel
findings, we hypothesize that microglial chemokine signaling and complement activation are critical for normal
retinal vascular development. We will refute or validate our hypothesis in the following two Specific Aims: Aim
1: To determine if chemokine signaling recruits microglia to modulate astrocyte template assembly. Aim 2: To
define the role of complement receptors in astrocyte template and vascular network formation. We will utilize
innovative multiplex RNA/protein based assays, novel ex vivo migration assays, unique reporter mice, and
cre/lox animals for cell-specific deletion. We expect that successful completion of the proposed studies will
identify novel roles for the innate immune system in regulating highly complex retinal vascular developmental
processes. Moreover, further elucidating physiological regulatory mechanisms of vascular development, will
also identify future putative therapeutic strategies for retinal vascular pathologies.

Public health relevance
Project Narrative Developmental retinal blood vessel formation is a complex and highly regulated process, and pathologies associated with aberrant formation or proliferation of retinal blood vessels are among the leading causes of blindness. A thorough understanding of retinal vascular development is necessary to better understand retinal vascular diseases. The proposed studies aim to understand the role of innate immunity in the regulation of retinal blood vessel development and elevate our understanding of how abnormal neovasculature arises.